NCHS-CDC NHIS Hearing and Balance Supplement

Hearing loss and balance impairment, including inner ear vestibular disorders (vertigo, other dizziness problems) can profoundly affect a person’s life and health; impacting the ability to work, interact socially and engage during health care encounters. Adults with hearing and balance disabilities are at risk for decreased quality of life, poorer health status, and diminished health care services received. Targeted interventions delivered in a community or medical setting, provided by audiologists, Ear, Nose, and Throat (ENT) doctors [aka, otolaryngologists-head and neck surgeons], neuro-otologists, occupational and physical therapists, pediatricians, gerontologists and other trained health care workers can potentially mitigate risks for long-term disability.

The ability of individuals to hear, like the ability to see, contributes immeasurably to quality of life. The hearing health of individuals affects their educational success, employment opportunities, workplace productivity (and safety), and social and mental health. Hearing loss is the third most common chronic physical condition in the US; it is twice as prevalent as diabetes or cancer. About 12 million (6 percent) American adults report they have “serious difficulty hearing or are deaf”. Approximately 50 million Americans have hearing loss of mild, moderate, severe, or greater degree in one or both ears. Hearing loss is one of the top three most prevalent chronic conditions in older Americans, together with hypertension and arthritis. As age increases, hearing loss can be so gradual that a person often is unaware of it until the loss becomes difficult to manage. Yet the prevalence of hearing loss doubles with each decade of advancing age. The number is expected to increase as the baby-boomer population ages; by 2030, nearly one in five U.S. residents is expected to be 65 and older. This age group is projected to increase to 88.5 million in 2050, which is more than double the number of adults over age 65 in 2008 (38.7 million).

The proposed questions on hearing and balance disorders were asked about children and adults (with some minor changes) in the 2014 National Health Interview Survey (NHIS) Hearing Supplement and the 2016 NHIS Balance and Dizziness Supplement. To maintain validity for cross-survey comparisons, wording has been standardized for hearing and balance questions asked during home interviews, prior to physical exams in mobile exam centers, in NHANES 2015-16, 2017-18, and 2019-23.

Advantages to obtaining the information from the NHIS include the large sample size (~13,000 children, ~35,000 adults) in a single year of data collection and the relatively quick availability of the data collected as Public Use files — approximately 6 months after data collection ends for NHIS each year. For timely analysis and release of information to the public and, also, to inform scientific research, NHIS is an appropriate nationally representative health survey of the civilian, non-institutionalized US population. These advantages are important as well for tracking and monitoring US Healthy People objectives.

Public health relevance
Hearing Loss: In 2010, the U.S. Preventive Services Task Force reviewed evidence on the efficacy of screening for hearing impairment in asymptomatic adults. They found evidence that hearing screening is associated with increased use of hearing aids. Although they did not find hearing screening resulted in improvements in hearing function, but that is not unexpected since most adult-onset hearing losses are permanent. However, a recent Cochrane Review reported substantial benefits in hearing-related quality of life (QoL) and small benefits in general health-related QoL among hearing aid users, so simply improving hearing aid uptake leads to improvements in health and well-being. The recent National Academies Review recommended that health care providers and public health agencies promote hearing health during medical and wellness visits, encourage patients to discuss concerns about their hearing, and refer to specialists, as appropriate. The review panel also recommended improving the affordability of hearing health care through improving coverage by health insurance plans, Medicare, and Medicaid. Finally, the panel encouraged the development of innovative models of hearing health care delivery – such as, community health outreach, telehealth applications, mobile health clinics, and self-administered care – that might improve access to and affordability of hearing care. Balance and Dizziness Disorders: Dizziness and imbalance are amongst the most common complaints in older people and are a growing public health concern since they put older people at a significantly higher risk of falling. Vestibular disorders are disorders of the body’s balance [vestibular] system in the inner ear. Causes of dizziness and imbalance are multifactorial, however, peripheral vestibular dysfunction is one of the most frequent causes. For example, benign paroxysmal positional vertigo (BPPV) is a frequent form of vestibular dysfunction; another vestibular condition is Meniere’s disease. Every factor associated with the maintenance of postural stability deteriorates during aging. Age-related deterioration of peripheral vestibular function has been demonstrated through quantitative measurements of the vestibulo-ocular reflex with rotational testing. Age-related decline of vestibular function has been shown to correlate with the age-related decrease in the number of vestibular hair cells and neurons. An estimated 40% of adults experience dizziness or imbalance at some point in their life. Left untreated, the results can be debilitating. As people get older, the onset of dizziness and falls from balance problems increases. These falls can lead to injury, hospitalization, surgery and even permanent disability. Dizziness and imbalance should not be accepted as inevitable effects of the aging process. Dizziness and balance disorders can affect people of any age, gender, race, or socioeconomic group. The symptoms may include whirling dizziness, unsteadiness or imbalance when walking, and nausea. These symptoms may be mild, lasting only minutes, or severe, resulting in total disability. • There are between 5 and 8 million visits to physicians or other health care providers for dizziness in the US each year. • Balance and dizziness problems are the leading reason for a physician visit for patients over age 75 years. Medical care costs for U.S. patients with balance disorders is estimated to exceed $1 billion per year.